Prototype Construction Core

PROJECT SUMMARY - PROTOTYPE CONSTRUCTION CORE (PCC)
The NEI sponsored research of investigators at the Stein Eye Institute (SEI) calls for the development and
modification of innovative spectroscopic, electrophysiological, optical and mechanical systems. To support
these efforts, a state-of-the-art computer numerical controlled (CNC) fabrication and engineering facility has
been established at the SEI. This facility enables the construction of novel devices and instruments that lead
NEI investigators into novel research areas. This facility is supported by the Prototype Construction Core
(PCC) Module of this core grant, and is one of the most heavily subscribed. The PCC module has these
notable features:
A. The facility continues to be operated by a formally trained CNC mechanician with a secondary
degree in electronics.
B. Access is provided to NEI grant holders throughout the UCLA campus who have need for
unique prototypes for research.
C. The facility provides training for research personnel unfamiliar with computer aided design and
fabrication.
D. The PCC provides project prioritization to streamline efficiency in fabrication, considering project
urgency.
E. The PCC facilitates synergistic use of the core components.
F. The PCC fosters collaborative relationships, particularly between translational and basic research
These features will be discussed in detail in our Research Strategy.